Defining the role of the mitochondrial protein, GOT2, in pancreatic cancer metastasis and epigenetic dysregulation

Project Summary
Pancreatic adenocarcinoma (PDAC) is a highly aggressive and deadly form of pancreatic cancer with a poor
prognosis and low survival rate. Despite advances in treatment and diagnosis, PDAC is still the third leading
cause of cancer-related deaths, often diagnosed at late stages, and resistant to chemotherapy and radiation
therapy due to its inherent tumor heterogeneity. The exact cause of PDAC is unknown, but several environmental
and genetic risk factors have been identified. Moreover, mutations in genes such as KRAS, TP53, SMAD4, and
CDKN2A have been reported as genetic drivers of PDAC progression. In recent studies, epigenetic changes
have been shown to play a significant role in the development and progression of PDAC, but the underlying
mediators that contribute to these alterations are largely unknown.
Previous studies have established a connection between mitochondrial proteins and epigenetic modifications,
contributing to the progression of tumorigenesis. Our research team has used mouse orthotopic tumor models
to recently report that the mitochondrial protein, GOT2 (glutamic-oxaloacetic transaminase), supports the
development of PDAC by exerting an immunosuppressive effect within the tumor microenvironment. Currently,
it remains unknown whether GOT2 contributes to the metastasis of PDAC, however, preliminary data seems to
suggest that GOT2 may play a role in modifying the epigenetic landscape in mouse PDAC cell line models. To
investigate this further, we have meticulously designed our methods to successfully carry out the aims outlined
in this proposal, utilizing in vivo mouse tumor models, as well as ChIP- and ATAC-seq experiments in conjunction
with bioinformatics approaches. The overall goal of our proposed aims is to gain a better understanding of the
mechanisms contributing the epigenetic dysregulation in pancreatic cancer and metastasis. We hypothesize
that GOT2 is pro-metastatic and plays a role in reprogramming the epigenetic landscape, which leads to
transcriptional profiles that facilitate the metastasis of PDAC. By revealing this new epigenetic role for
GOT2, we hope to gain a deeper understanding of the transcriptional and epigenetic programs that enhance the
plasticity of tumor cells and drive the progression of PDAC. Ultimately, this will provide new opportunities for the
development of more effective treatments to address the increasing medical and societal burdens of pancreatic
cancer.

Public health relevance
Project Narrative Pancreatic adenocarcinoma (PDAC) is a deadly form of pancreatic cancer with a poor prognosis and low survival rate, largely due to its late-stage diagnosis and resistance to chemotherapy and radiation therapy. Epigenetic alterations are known to play a role in the progression of PDAC toward metastasis, but the underlying mediators are largely unknown. This proposal aims to examine the epigenetic landscape of pancreatic cancer and define a novel role for the mitochondrial protein GOT2 (glutamic-oxaloacetic transaminase) in epigenetic reprogramming and in promoting PDAC metastasis.